The role of astrocytes in the pathogenesis of sporadic tauopathy

PROJECT SUMMARY
Tauopathies are a group of heterogeneous neurodegenerative diseases characterized by pathological
aggregation of tau protein in the brain. The most common primary tauopathy, progressive supranuclear palsy
(PSP), is identified clinically by progressive parkinsonism with supranuclear gaze paralysis, cognitive
dysfunction, behavioral changes, and other neurological deficits. Neuropathologically, PSP has a constellation
of features including morphologically distinct tufted astrocytes (TA). Astrocytes normally do not contain significant
levels of tau suggesting that TA play an important, but unknown, pathological role in PSP. The majority of PSP
cases are sporadic. Genome wide association studies have identified common variants associated with PSP risk
in EIF2AK3, which encodes an endoplasmic reticulum (ER) stress sensor critical for the unfolded protein
response (UPR). There is evidence for a pathogenic association between ER stress in astrocytes and tau
accumulation in PSP, but to test candidate molecular mechanisms there is a critical need for a model system
that recapitulates the cellular environment of the human brain and retains the genetic complexity of human
disease. Developing human induced pluripotent stem cell (iPSC)-derived models generated from PSP patients
will be a powerful tool to characterize molecular drivers of sporadic tauopathy. We hypothesize that UPR
activation in astrocytes drives neurodegeneration and plays a key role in sporadic PSP. In our first aim, we will
correlate UPR activation with astrocyte pathology and degeneration in human post-mortem brain tissue.
Autopsy-confirmed PSP brain tissue from our large collection will be stained, imaged, and analyzed for p-tau
distribution and UPR colocalization using innovative quantitative approaches. In the second aim, we will test the
hypothesis that PSP neurons and astrocytes are highly vulnerable to tau pathology, and that UPR activation in
PSP astrocytes increases cell vulnerability. To accomplish this aim, we will create patient iPSC-derived
monolayer neurons and astrocytes and directly measure molecular changes and cell vulnerability by
pharmacological manipulation of the UPR. Lastly, we will determine the extent to which UPR activation in
astrocytes increases the production of toxic tau species and cell vulnerability in an iPSC-derived organoid model
of sporadic PSP. This aim will explore molecular perturbations in different cell populations that contribute to the
development of tau pathology in a 3-D cellular environment that recapitulates the complex neuronal-astrocyte
interactions that occur in human brain tissue. These findings will be validated in paired autopsy brain tissue from
the same donor. In summary, the clinical-translational research performed in this study will generate patient-
derived iPSC models that retain a disease-relevant genomic background and reveal candidate pathways that
are disrupted early in sporadic PSP.

Public health relevance
PROJECT NARRATIVE The work proposed in this fellowship will reveal candidate pathways that are disrupted in sporadic PSP and has the potential to create a paradigm shift in disease model systems by revealing the extent to which iPSC- derived models recapitulate disease pathology in the human brain.